Non-Classical Cytokine Secretion in Chronic Airway Disease

Abstract for the Parent Grant
Chronic lower respiratory tract disease is a major cause of morbidity and mortality in the U.S. and worldwide.
Currently there are no effective disease-modifying therapies and it remains unclear how to define and
optimally treat disease endotypes within the spectrum of asthma and COPD (chronic obstructive pulmonary
disease; chronic bronchitis and emphysema). This mechanistic research aims to define new pathways
amenable to therapeutic intervention based on the role of diseased airway epithelial cells as an upstream
driver of chronic airway disease. As a foundation for this proposal, multiple human clinical and translational
studies as well as allergen- smoke- and virus-induced animal models have solidified the relevance of the
pathogenic epithelialderived cytokine IL-33 in COPD and asthma. However, a major knowledge gap that
remains is understanding the mechanism by which nuclear-sequestered IL-33 can be activated and secreted
from diseased airway cells to drive inflammation. Here we present preliminary data that demonstrates
human COPD airway epithelial cells express increased levels of a truncated, spliced IL-33 isoform, which is
capable of escaping nuclear sequestration to be abundantly secreted. Our analysis further revealed novel
features of this secreted IL-33 isoform including post-translational modification, interaction with exosome-
associated chaperones, and utilization of exosome trafficking pathways for secretion. Accordingly, this study
aims to elucidate the impact of these newly-discovered features of IL-33 biology on the pathogenesis of
chronic airway disease. Aim 1 will define how IL-33 interaction with exosomal chaperones enhances
cytokine secretion and receptor activation to drive airway disease, using human cellular and mouse airway
disease models coupled with validation in human airway disease specimens. Aim 2 will investigate the role
of post-translational modification in augmenting IL-33 secretion and receptor activation to propagate
disease, through an analogous approach using human cellular and mouse models with validation in human
specimens. Together, these aims will address key steps in the pathologic sequence that initiates and
sustains chronic airway disease, illuminating novel ways to target exosome-mediated cytokine secretion at
the mucosal interface
Abstract for the Supplement
Chronic lower respiratory tract disease is a major cause of morbidity and mortality in the U.S. and worldwide.
Currently there are no effective disease-modifying therapies and it remains unclear how to define and optimally
treat disease endotypes within the spectrum of asthma and COPD (chronic obstructive pulmonary disease;
chronic bronchitis and emphysema). This mechanistic research aims to define new pathways amenable to
therapeutic intervention based on the role of diseased airway epithelial cells as an upstream driver of
chronic airway disease. As a foundation for this proposal, multiple human clinical and translational studies
as well as allergen- and virus-induced animal models have solidified the relevance of the pathogenic
epithelial-derived cytokine IL-33 in COPD and asthma. However, a major knowledge gap that remains is the
relevant form of IL-33 secreted from diseased airway cells to potently drives inflammation in vivo. To that end,
we have found that human COPD airway epithelial cells produce increased levels of a truncated, spliced IL-
33 isoform that is tonically secreted. Our analysis further revealed this secreted IL-33 isoform is uniquely
phosphorylated through protein kinase C pathways. Recognizing that currently available commercial
antibodies do not specifically recognize alternatively spliced or modified IL-33 isoforms, in this
administrative supplement we aim to develop and validate monoclonal antibodies for detection of this
disease-associated IL-33 variant. Aim 1a will involve immunization of mice with the truncated, spliced IL-33
variant lacking exons 3 and 4 (IL-3334) in both phosphorylated and unmodified forms, hybridoma fusion
and screening of clones in ELISA format. Aim 1b will involve measurement of phosphorylated and
unmodified IL-3334 levels in human lung tissue and bronchial wash from non-COPD and COPD specimens.
Together, these aims will address key features of chronic airway disease that may serve as novel
biomarker assays and inform development of anti-IL-33 therapeutics.

Public health relevance
Project Narrative/Public Health Relevance for Parent Grant Chronic Obstructive Pulmonary Disease is a major cause of morbidity worldwide and the 3rd leading cause of death in the United States. There are no cures for this disease and the standard forms of treatment often do not provide adequate relief, as much of the morbidity and mortality is due to mucus obstruction of the airways. There are currently no specific and effective therapies available for excess mucus production. The proposed work aims to identify new ways to treat this disorder by investigating the source of inflammation and mucus overproduction in the airways, thereby addressing a previously unmet need for treatment of a major public health problem. Project Narrative/Public Health Relevance for Supplement Chronic Obstructive Pulmonary Disease is a major cause of morbidity worldwide and the 3rd leading cause of death in the United States. There are no cures for this disease and the standard forms of treatment often do not provide adequate relief, as much of the morbidity and mortality is due to mucus obstruction of the airways. The proposed work aims to identify new ways to detect and potentially treat this disorder by investigating the source of inflammation and mucus overproduction in the airways, thereby addressing a previously unmet need for treatment of a major public health problem.